Diabetes Modeling Core

DIABETES MODELING CORE
SUMMARY ABSTRACT
The overall mission of the Diabetes Modeling Core (DM core) is to provide diabetes researchers with access to
novel human stem cell-derived in vitro cell models and genetically-engineered murine models (GEMMs) for
investigating cellular and molecular features of both Type 1 and Type 2 diabetes. Recent progress in stem cell,
organoid culture, gene editing and directed differentiation technologies has afforded unique opportunities to
develop state-of-the-art pre-clinical human in vitro diabetes models. Similarly, GEMMs of diabetes mellitus
continue to provide crucial insights into developmental processes and disease mechanisms. However,
because of the complex experimental protocols and specialized reagents used, together with the considerable
up-front costs and time required to develop these sophisticated models, it is not practical nor cost-effective to
develop these models in individual laboratories. To remove these barriers, the DM core will provide the
expertise, infrastructure and access to these model systems and technologies. This goal will be achieved in
three ways: 1) providing access, support and training in current and emerging pluripotent and adult stem cell
technologies for in vitro human disease modeling; 2) providing access and support in current and emerging
genetically-engineered mouse models and 3) providing validation, authentication and data sharing of all DM
core-related technologies. Thus, the overall mission of this core is to facilitate access, generation and usage of
novel diabetes models and to promote innovative basic and translational diabetes research at UC AMC.

Public health relevance
DIABETES MODELING CORE NARRATIVE The overall mission of the Diabetes Modeling Core is to provide diabetes researchers with access to novel human stem cell-derived in vitro cell models and genetically-engineered mouse models for investigating cellular and molecular features of both Type 1 and Type 2 diabetes. We will provide expertise, resources and training in these start-of-the-art stem cell technologies together with rigorous quality control testing, standardization and authentication to promote innovative basic and translational diabetes research.